Mentoring Research Excellence in Aging and Regenerative Medicine

Aging is a process that is the major risk factor for chronic disease and degeneration. However, it is beginning to
be appreciated that disease and degeneration impinge on biological aging, in something akin to a feedback loop,
suggesting that a better knowledge of one contributes to an understanding of the other. This necessitates that
development of therapeutic interventions must address the degenerative disorders of aging, while the search for
broad interventions that target the biological aging process itself continues. This agenda calls for the creation
and nurturing of an environment in which multidisciplinary research of sufficient breadth is focused on key
elements of aging and regeneration. At the same time, it is necessary to populate this translational space with
talented and successful investigators. The project goals are to: (1) Continue to expand the number of aging and
regeneration research-oriented, funded investigators within the scientific community at Tulane through pilot
projects, with emphasis on collaborative research, and to provide a mentoring program for these researchers
and others that supports successful career development. (2) Maintain the state-of-the-art infrastructure to provide
sustainable resources that continuously enhance the competitiveness of center faculty for national funding, by
expanding and updating the services performed by our Genomics, Bioinformatics, and Spatial Multiomics Core.
(3) Cement the position of the Tulane Center for Aging at the forefront of aging and regenerative medicine by
growth of its thematic, multidisciplinary research foci to facilitate successful extramurally funded collaborations
that will support and sustain the center. The COBRE project leaders have coalesced into four research foci, one
of which is Musculoskeletal and Soft Tissue Adaptation and Homeostasis. It is this area that is targeted for this
administrative supplement. Extrinsic and intrinsic damage to body organs is constantly a threat to homeostasis
during aging. Bodies can repair such damage rather well if it is not too severe. In fact, there are a few examples
of near perfect repair that we can call regeneration, such as the regeneration of the digit tip. However, if the
damage is extensive or chronic, the result is pathological healing that leaves behind a fibrotic scar compromising
organ function. Virtually all organs are capable of repair and renewal and are prone to this pathology to a lesser
or greater extent. The premise is that there are similarities, at the molecular and cellular levels, in fibrosis in
these various organ systems, in addition to the differences, that can illuminate the factors that contribute to
regeneration rather than fibrosis. These factors may best be uncovered using a comparative approach in several
organ systems. To best leverage this approach, a team of experts in repair, regeneration, and fibrosis, in several
different organs will be assembled, starting with the amputated digit tip and the damaged lung, along with experts
in bioinformatics to facilitate unraveling its complexity in these organ systems. Their singular goal is to elucidate
fibrosis – repair gone wrong. Fibroproliferative disorders account for 45% of the deaths in the United States, thus
this research has significant public health impact.

Public health relevance
Fibroproliferative disorders account for 45% of the deaths in the United States, but thus far antifibrotic drugs have been largely ineffective. These disorders affect virtually every organ in the body, contributing not only to mortality but also to morbidity. Finding effective treatment will be a game changer, and this is the ultimate goal of this research.